Centers of Excellence for Influenza Research and Surveillance

This interagency agreement is part of NIAID's Centers of Excellence for Influenza Research and Surveillance program and supports basic research on Avian influenza.